HOW TANF AGENCIES SUPPORT FAMILIES EXPERIENCING HOMELESSNESS

The purpose of this descriptive study is to understand the extent to which TANF agencies across the country are using TANF funds to serve and support families experiencing or at-risk of homelessness. It also will document the approaches and strategies used by TANF agencies to serve these families. This project will include a systematic review of state and territory TANF agencies’ policies; TANF administrator surveys at both the state and selected county levels; site visits to TANF agencies; interviews with agency staff; and focus groups of TANF recipients experiencing or at-risk of homelessness.